Fellowship Training Program in Vaccinology

PROJECT SUMMARY
Vaccination has had a remarkable impact on the health of the world’s population and has been shown to be a
safe, cost-effective, and powerful means of preventing deaths and improving quality of life. The University of
Maryland Center for Vaccine Development and Global Health (CVD) training grant in Vaccinology has been
training exceptional vaccine scientists for 25 years. Our program is firmly anchored on our past successes but
has rapidly incorporated innovative new technologies, cutting-edge strategies, state of the art data analytic tools
and novel educational approaches to train the next generation of leaders in Vaccinology. Collectively, the 35
faculty members participating in this training grant represent one of the largest and most accomplished teams of
academic vaccine researchers in the country. These faculty study all phases of Vaccinology, each through their
independent, established and well-funded research programs, and have been selected not only for their
particular expertise but for their experience and commitment to training postdoctoral MDs and PhDs in vaccine
research. Our highly regarded, well-established program includes a basic core curriculum designed to convey
the interdisciplinary nature of the field and provide context for the specific area of research to be pursued by the
trainee. Additional academic work, including required training in the responsible conduct of research,
professional development, and a highly structured mentoring program, will be combined with a tailored research
experience in one of two tracks: 1) Pathogenesis, Immunology and Antigen Discovery Track – preparing basic
and physician scientists for a career in laboratory research, or 2) Clinical, Epidemiologic Science and Policy
track -preparing physician-scientists and PhD epidemiologists in human controlled infection models, clinical trial
study design and execution, and vaccine policy and epidemiology. Recruitment of trainees from
underrepresented minorities is given high priority through innovative programs at the University and those
specific to our training grant. Our training program is led by two Co-directors, with specific skills in the two
investigative tracks and both highly qualified, and is guided by Internal and External Advisory Committees
comprised of internationally recognized leaders in academic medicine and Vaccinology. The ultimate measure
of our training program is to prepare our trainees to become leaders in academia, government and the private
sector, and to contribute new knowledge in Vaccinology measured by excellent records of publications, funding,
and awards.

Public health relevance
PROJECT NARRATIVE Future advancements in our ability to develop, license and deploy effective vaccines against infectious and non- infectious diseases depend on advanced training of scientists in the multidisciplinary, rapidly evolving field of Vaccinology. This T32 Training Program in Vaccinology provides post-doctoral fellows with training in the performance of “bench” research and/or clinical studies and the analytical skills required to critically posit, evaluate, and advance focused and relevant scientific questions within the broad field of Vaccinology. Towards this goal, talented trainees receive exceptional academic support, research guidance, and mentoring from our dedicated faculty, as evidenced by the scientific and career successes of our prior trainees in the last two decades of this grant.